MASH Pathogenesis and Therapeutic Approaches

ABSTRACT
Support is requested for a Keystone Symposia conference entitled MASH Pathogenesis and Therapeutic
Approaches organized by Drs. Elizabeth K. Speliotes, Rebecca A. Taub and Hannele Yki-Järvinen, with scientific
programming input from Keystone Symposia. The meeting will take place February 23–26, 2025 at Fairmont
Banff Springs, Banff, AB, Canada.
Elevated rates of obesity are linked with an increase in metabolic dysfunction-associated steatotic liver disease
(MASLD), which may progress to metabolic dysfunction-associated steatohepatitis (MASH), cirrhosis, and liver
cancer. The incidence and prevalence of liver disease is rapidly increasing and affects a significant percentage
of the world’s population, with concurrent increases in liver disease-related morbidity and mortality. Moreover,
despite intensive research efforts, there remain gaps in the understanding the drivers of liver disease, and at
present, there are no effective medical treatments for MASLD/MASH. This Keystone Symposia conference will
explore the underlying mechanistic links between obesity and liver disease, as well as focus on advancing both
basic and translational elements of metabolic disease research. Accordingly, this conference has been paired
with another Keystone Symposia conference, Obesity and Adipose Tissue. This is a synergistic pairing, given
that lipodystrophy has long been known to promote severe MASLD. Further, new therapeutic approaches,
including bariatric surgery and now GLP-1 and dual GLP-1/GIP agonists, are showing clinical effectiveness for
remediation of obesity, but are also being tried for MASLD. Shared keynote and joint scientific sessions will
promote interaction and foster collaboration between endocrinologists, hepatologists and liver biologists to
identify novel strategies to curb liver disease.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction-associated steatotic liver disease (MASLD), which is caused by the storage of excessive fat deposits in the liver, is a growing health burden worldwide. This disease can lead to a chronic liver inflammation condition known as metabolic dysfunction-associated steatohepatitis (MASH) and progress to other life-threatening diseases for which there are no effective medical treatments at present. Together with another Keystone Symposia meeting, Obesity and Adipose Tissue, this conference will cover the latest developments in MASLD and obesity towards a better understanding of these diseases and the development of new therapies.